ADMINISTRATIVE

The Administrative Core (Core A) will provide the mechanism to plan, evaluate, and manage the four Projects and two other Gores in this proposed Program Project (PPG). The goals of Core A are to provide scientific, programmatic, and fiscal leadership and facilitate communication between all researchers to ensure that the Projects fulfill the goals set forth in the proposal and meet the administrative and financial requirements ofthe NIH, the University of Rochester and the two other institutions involved, Harvard Medical School in Boston, and the Albert Einstein College of Medicine in New York. Core A will facilitate monthly meetings by videoconference and annual face-to-face meetings. The Core will also be responsible for the communication between the PPG and the NIH. Further, the Core will ensure that the results of each Project are disseminated in a timely manner for the benefit of the scientific community. To this end. Core A will facilitate the submission of joint publications and, in collaboration with Core C, will maintain a database for all biological specimens and data generated by the Projects and Cores. Finally, Core A will establish the external Scientific Advisory Board and will organize biennial reviews by this board.

Public health relevance
The Administrative Core will be responsible for maintaining cohesion and synergy between the different projects and cores by facilitating the interaction and exchange of information and materials between project participants. The Core will ensure that the project goals are met, oversee dissemination of data, as well as fiscal management, adherence to NIH rules and regulations, and interaction with the NIH.